VIRUS-CELL INTERACTIONS &HOST FACTORS IN HIV PATHOGENES

We have characterized several new strains of HIV group O by nucleotide sequencing. Specifically, the regulatory genes tat, nef, vpu and vpr have been sequenced. Studies are underway to evaluate the replication of non clade B and HIV-1 Group O viruses and drug resistant viruses in in vitro cell systems. We have initiated studies to identify new variants and recombinants of HIV and related viruses. These viruses will be investigated for their infectivity, drug susceptibility and pathogenesis in appropriate cell culture systems and animal models. We have examined the impact of HIV variation on apoptosis, chemokine and cytokine production in donor PBLs. We will also examine the role of tat and nef in faciltitating fasL mediated apoptosis in PBLs and dendritic cells. These studies will be also carried out in SCID mice. Effects of tat and nef on the regulation of chemokines in susceptible dendritic cells are being investigated. The infectivity of different HIV subtypes and variants for dendritic cells and macrophages are being studied.